TECHNICAL CORE

We are requesting support for a Core Unit to integrate the administrative and scientific activities of the Program Project, thus relating directly to the communal needs of the five individual projects. These needs include program administration, one centralized technical facility (tissue culture laboratory), service contracts for common equipment, supplies (e.g liquid nitrogen), travel to national meetings, and external consultation.